Genie:S: On-Demand Sulfide Synthesis and Delivery Platform Technology for Ischemia Therapy

Project Summary/Abstract
Peripheral artery disease (PAD) is a vascular insufficiency problem that affects more than 20 million or nearly 7% of the
U.S. population. Nearly 1 in 10 PAD patients eventually develop chronic limb threatening ischemia (CLTI) with a combined
annual cost of $21B. PAD is caused by sustained endothelial dysfunction, which is a vascular disorder prevalent among
smokers and diabetics, and it is often missed until the symptoms become advanced enough to lead to CLTI. The resulting
lower extremity ischemia in CLTI patients is associated with 25% limb loss and 25% mortality at the end of year 1. Hydrogen
sulfide (H2S) is an endogenous gasotransmitter and signaling molecule synthesized by the endothelial layer. In addition to
vasodilatory role, H2S is responsible for angiogenesis in endothelial cells through activation of pathways that include nitric
oxide signaling and the canonical HIF-1 and VEGF-A-mediated angiogenesis cascade. There is also significant evidence
linking deficiency in endogenous H2S to endothelial dysfunction and consequently microvascular disorder and poor
perfusion. Systemic administration of (exogenous) H2S donors has been shown to markedly improve the rate of
regeneration in ischemic tissue. However, widespread clinical translation of systemic H2S therapy is stymied by significant
concern over its safe use and unintended off-target effects due to a lack of control and knowledge over the dosage during
treatment. This leaves a significant opportunity for a disruptive approach for targeted, precision delivery of H2S to facilitate
clinical translation of H2S therapy. The proposed preclinical SBIR study, which is a collaboration between Exhalix and the
University of New Mexico School of Medicine, will demonstrate the unique platform technology, Genie:S, that local-
regionally synthesizes and delivers a controlled amount of H2S for a variety of topical clinical applications. We anticipate
that the proposed feasibility study will last 12 months and success in reaching our objectives will lead to a Phase II effort
for the development of advanced prototypes and pre-clinical studies on small and large animals.

Public health relevance
Project Narrative Peripheral artery disease (PAD), caused by endothelial dysfunction, and consequently formation of atherosclerotic plaque in large arteries and low blood perfusion in the peripheral microvasculature can lead to tissue ischemia and chronic wounds. In the case of end-stage or desert foot with limited options, tissue ischemia in lower limbs often leads to amputation and mortality. This proposal addresses the need for a novel platform technology to accelerate clinical translation of H2S therapy, proven to make a major impact on accelerating vascularization and perfusion recovery.